NATIONAL SPATIOTEMPORAL POPULATION RESEARCH INFRASTRUCTURE

Project Summary
With 382 billion data points, NHGIS is the largest publicly accessible population database in the world and is
an essential component of the shared data infrastructure for population and health research. Over the past 16
years, NHGIS has collected aggregate U.S. census data from diverse sources, formatted them consistently,
developed machine-readable documentation, and created high-precision boundary files describing census
geographic units over time. To eliminate major obstacles for studies of small-area population change, NHGIS
has developed geographic time series that link comparable data across multiple census years. The data are
broadly accessible to health researchers through powerful dissemination tools that make it easy to navigate the
intricacies of the U.S. statistical system.
The availability of large-scale integrated census data has opened exciting new opportunities for fine-grained
contextual analyses of population dynamics and health. These data are essential for spatial analysis of
mortality and disease incidence and for assessing the impact of neighborhood characteristics on health and
well-being. NHGIS reduces costs for population and health researchers by minimizing redundant effort,
simplifying data access, and improving data reliability. Over the past five years, the number of NHGIS users
has increased 250%, and the project now disseminates seven terabytes of data per year. To meet the
demands of a rapidly increasing user base and ever-expanding requests for more and improved data, this
project has five major goals:
1. Ingest of new census data. The quantity of data in NHGIS will expand dramatically over the coming five
years to include tabular and spatial data from the 2020 decennial census and 2017-2021 ACS.
2. GIS boundary files for 1970 and 1980 census blocks. The project will create and disseminate boundary files
delineating 1970 and 1980 census blocks, the finest-resolution units identified in census summary data.
3. New and extended spatiotemporal data tables. The project will (1) extend time series to 2020; (2) extend
geographically standardized times series back to 1970 and 1980; (3) create spatial relationship files for
standard census units over time; (4) create annual tract population estimates by sex and age, 1990-2020.
4. Data access tools. The project will (1) create and publish software to generate spatially consistent zones
from any set of mismatched zones; (2) provide users with greater flexibility to select and obtain data for
specific geographic extents; (3) design and implement continued interface and system refinements.
5. Dissemination, training and outreach. We will provide user support, webinars and outreach to users.

Public health relevance
Project Narrative Using NHGIS data, researchers are advancing fundamental knowledge about health and population dynamics. These data are essential for spatial analysis of mortality and disease incidence and for assessing the impact of neighborhood characteristics on health and well-being. NHGIS reduces costs for population and health researchers by minimizing redundant effort, simplifying data access, and improving data reliability. The data directly support a vast body of research in one of the key priorities of the Population Dynamics Branch (PDB) of NICHD: Health and Disease across the Lifespan.